SBIR Phase I Topic 410 - Cancer Clinical Trials Recruitment and Retention Tools for Participant Engagement.

The proposed contract is designed to refine and test the feasibility and usability of a Deep Learning Clinical Trial Matching System (DLCTMS) for improving accrual across multiple oncology trials at an NCI-designated Cancer Center (NCICC). This project explicitly meets NCI-identified needs for clinical trial support tools that a) identify protocol barriers to recruitment and present options for addressing the challenge, b) identify effective recruitment strategies, c) integrate with electronic medical records, d) allow for tracking screening efforts, d) are easily adaptable for different trials, e) include provider-based tools to facilitate discussion with potential participants, f) provide access to peer mentors and patient navigators, and g) increase awareness and provide easy access to information on all ongoing clinical trials.